Prevention of anal cancer in People Living with HIV (PLWH)

The incidence of anal cancer, which is largely caused by sexually transmitted human papillomaviruses (HPVs),
has been increasing for many years, especially in people living with human immunodeficiency viruses (HIV+).
The Department of Veterans Affairs cares for the largest population of people living with human
immunodeficiency virus of any healthcare system in the nation. One opportunity for preventing this deadly
cancer lies in the effective treatment of precancerous anal intraepithelial neoplasia (hereafter referred to as
anal dysplasia). Unfortunately, current treatments for anal dysplasia are ineffective, with high recurrence rates
and unwanted, long-term side effects. Dr. Carchman’s laboratory studies anal carcinogenesis in a well-
validated, HPV-transgenic model. Through collaborations Dr. Carchman also has access to a new conditional
transgenic mouse model to study anal carcinogenesis to facilitate mechanistic studies and test therapeutic
agents. Dr. Carchman has identified autophagic dysfunction due to HPV16 E6 and E7 expression that results
in anal cancer development. Dr. Sherer’s laboratory has determined that HIV-1 protease inhibitors result in the
degradation of HPV E6 and E7, which prevent the destruction of p53, a potent inducer of autophagy. These
findings have led the team to pursue preclinical studies that re-purpose HIV protease inhibitors—previously an
integral part of HIV treatment—in a topical form to treat anal dysplasia and prevent cancer development. While
protease inhibitors have been shown to induce autophagy in several preclinical and clinical studies, they have
not been examined in anal dysplasia treatment. The overall hypothesis is that autophagic induction with
topical protease inhibitors will prevent the progression of anal dysplasia in preclinical models of anal
carcinogenesis, thus providing an effective therapeutic option to prevent HPV-associated anal cancer in
humans. The goal of this proposal is to utilize novel preclinical models of HIV-associated anal carcinogenesis,
which include a single-cell culture where E6 and E7 are green fluorescent protein (GFP) tagged, an
established HPV-transgenic model, and a conditional HPV transgenic model that will undergo immune
modulation to recapitulate HIV infection. The team is uniquely positioned to carry out this proposed study. Dr.
Carchman has clinical expertise in anal dysplasia and anal cancer and is the leader of the anal
dysplasia/cancer clinic at the University of Wisconsin-Madison. The group also has extensive expertise with
preclinical models for anal carcinogenesis. These models recently yielded the key observation that autophagy
is important for inhibiting anal carcinogenesis—a discovery that drives the proposal’s central premise that HIV
protease inhibitors, known to induce autophagy, can be re-purposed as topical agents to prevent anal cancer.
The team’s work brings a cancer-relevant problem in the context of an HIV infection back into focus. This
research is well-grounded in existing methodology, supported by preliminary data, and holds promise for new
treatments to prevent HPV-associated cancers. The project will also advance the development of innovative
preclinical models for studying anal carcinogenesis and testing new therapies.

Public health relevance
Anal cancer is caused mainly by sexually transmitted human papillomaviruses and has been increasing in incidence for many years—especially in adults living with HIV. In fact, people living with HIV have a 100x increased risk for anal cancer compared with HIV-negative patients. The VA cares for the largest population of patients living with HIV of any healthcare system in the United States, over 25,000 Veterans in 2019. One opportunity for preventing this deadly cancer in high-risk individuals lies in the effective treatment of precancerous lesions. The proposed research uses several novel preclinical models of anal cancer to examine the efficacy of targeted, topical therapies.